Cannabidiol as an Adjunct Treatment for Alcohol Withdrawal and Craving

Project Abstract
This project aims to assess the capacity of cannabidiol (CBD) to manage alcohol withdrawal and cravings
during detoxification of patients with Alcohol Use Disorder (AUD). AUD is associated with physical and
psychiatric consequences as well as exorbitant healthcare costs. Attempts to treat AUD are limited by alcohol
withdrawal, which can itself lead to seizures and death if it is not adequately treated. Benzodiazepines have
long been the gold standard in the treatment of alcohol withdrawal, but this class of medications has
drawbacks including abuse liability that limits its utility in an outpatient setting, adverse effects such as delirium
and respiratory depression at high doses, and a susceptibility to shortages. Thus, there is a need to identify
novel adjunct treatments for the management of alcohol withdrawal that could reduce benzodiazepine use and
further attenuate withdrawal. CBD, one of the main cannabinoids in the Cannabis sativa plant, possesses
several attributes that could make it a suitable treatment for alcohol withdrawal: it has a relatively benign side
effect profile, lacks abuse liability, and has evidence to manage symptoms seen in alcohol withdrawal,
including anxiety, insomnia, and seizures. CBD’s potential to help manage alcohol withdrawal symptoms and
craving behaviors has been shown in preclinical studies but there is no data on CBD’s role as a treatment for
alcohol withdrawal in human participants. This study will fill this knowledge gap by recruiting individuals with
moderate-to-severe AUD to participate in a four-day inpatient study where they will be randomized to receive
either placebo solution or CBD solution at a daily dose of 10 mg/kg or 20 mg/kg while undergoing supervised
medical detoxification. Withdrawal will be assessed by nursing via the Clinical Institute Withdrawal
Assessment, revised (CIWA- Ar) and by participant self-report via Alcohol Withdrawal Symptom Checklist
(AWSC). CIWA scores will guide administration of benzodiazepines for the treatment of withdrawal symptoms.
We will measure sleep quality through both self-report via the Consensus Sleep Diary (CSD) and objective
data collected through wrist actigraphy. Alcohol cravings will also be measured via participant self-report with
the Alcohol Urge Questionnaire (AUQ). Additionally, we will measure changes in liver function to verify the
hepatic safety of CBD at these doses. Analysis will involve comparison between groups of the scores on the
assessments of withdrawal, craving and sleep, wrist actigraphy data, total number of lorazepam doses
administered over the course of study, and changes in liver function and vital signs. We hypothesize that CBD
will be well-tolerated and attenuate alcohol withdrawal symptoms and cravings in a dose-dependent manner
compared to placebo. Results from this study could position CBD as a novel agent for the management of
withdrawal, sleep and cravings in early abstinence.

Public health relevance
Project Narrative Alcohol Use Disorder (AUD) is a leading cause of morbidity and mortality, and treatment attempts are obstructed by a withdrawal syndrome that is itself associated with debilitating psychiatric and physical symptoms that can be fatal if not adequately managed. Treatment options are limited, yet cannabidiol (CBD) may offer benefits based on observations that it can reduce symptoms seen with withdrawal (anxiety, insomnia, and seizures) and may have a mechanism similar to benzodiazepines (currently the leading treatment medication for alcohol withdrawal). With its excellent safety profile and reduce abuse liability, CBD may provide additional therapeutic benefit as an adjunct treatment during medically supervised alcohol withdrawal.